Spatial single cell analysis of the human Alzheimer's Disease brain

SUMMARY
The major goal of this project is to study human Alzheimer’s Disease (AD) brains using the
Spatial Genomics GenePS instrument for automated large scale gene expression analysis at
single cell resolution. At Spatial Genomics, we are commercializing the sequential fluorescence
in situ hybridization (seqFISH) technology (Eng et al, 2019) that allows thousands of genes to
be imaged directly in brain samples. We have experience working with human brains with our
seqFISH technology and will hone the technology for use in human brains. Using the seqFISH
method, we will identify changes in cell types, spatial organization of groups of cells, and
signaling interactions between neighboring cells in the human AD brain.

Public health relevance
NARRATIVE Studying the changes in the spatial organization and gene expression in human Alzheimer’s Disease brains is crucial to understanding the disease process. Spatial Genomics is commercializing a technology to spatially map the molecular states of single cells in the context of neuropathological markers. This technology can identify cell types and the signaling interactions between adjacent cells in the brain to map the molecular processes in a cell type specific fashion in human AD brains.